Overcoming Neurogenic “Meta-Inflammation” to Promote Recovery After Spinal Cord Injury

Abstract - Supplement PA-20-272
No changes from parent grant. See Supplement Research Plan for supplement specific
information.

Public health relevance
Project Narrative: The singular goal of most spinal cord injury (SCI) research programs is to repair the injured spinal cord and restore locomotor function. Unfortunately, restoration of walking is a low priority for most SCI individuals. In addition to impaired mobility, SCI causes slow and steady pathological changes in organ systems throughout the body. Failure to recognize and treat multi-organ system pathology as a standard of care may explain why survival rates have not improved for SCI patients (relative to able-bodied individuals) over the past 30 years. Experiments in this proposal are designed to study SCI as a disease of the entire body and will yield novel data that will ultimately promote recovery of function and quality of life (QoL) after SCI.